Mechanisms of Working Memory Capacity Limits and Their Development

PROJECT SUMMARY/ABSTRACT
BACKGROUND: Working memory (WM) is the limited information retained in an active state for use in
ongoing cognition. Improvements in WM from 6-14 years are critically important for how children do diverse
cognitive functions like reasoning, problem-solving, and language. When teaching children (typical or
challenged), little is known about how to take into account WM limits because we do not yet understand what
factors contribute to typical WM development. Research by the P.I. under Grant R01-HD-21338 shows that
accounts of WM development that have been proposed are insufficient (e.g., improvement in ignoring
distraction or in item familiarity). We have shown this using methods in which the factors in question were
experimentally controlled in new ways (e.g., capacity growth was observed independent of any distraction or
familiarity effects). In my theoretical framework, WM capacity limits come from how many items can be
retained concurrently in the focus of attention with enough detail to guide responses. In a new developmental
hypothesis within that account, the number of WM items may remain fixed but WM develops in the richness of
features within items and patterns noticed across items. Older children and adults would use features and
patterns to minimize the need for attention to WM items. The RESEARCH GOAL is to assess this hypothesis
with variants of new dual-set (e.g., visual+acoustic) recognition tasks, to identify roles of attention, patterns,
and features in typically developing children and young adults. SPECIFIC AIMS are to uncover these bases of
WM development in four ways. (1) We assess whether it is not just the number of items or objects in WM that
increases in development, but the completeness of their feature representations. (2) Inasmuch as our previous
work demonstrated the importance of general attention to retain information in WM, we explore a factor that
may free up attention in more mature participants. Older children may engage in rapid pattern formation and
memorization to “off-load” materials out of the focus of attention, freeing attention for subsequent input and
WM maintenance. We examine whether extra structure in the material allows younger children to off-load
more like older ones do. (3) We recently found that off-loading occurs for acoustic and verbal lists (words or
tones) much more than for visual arrays, reducing interference between acoustic items and other items. We will
investigate the basis of these intriguing findings. Possibly, sequential lists of colored spots, like acoustic
sequences, will allow better off-loading than do arrays of spots. We also will examine whether vibrotactile
sequences compete with visual objects for attention, more than do acoustic items. Last, (4) we adopt
experimental techniques from recent adult work to determine whether attention-dependent and attention-free
mechanisms both develop similarly in terms of a) an increased numbers of items in WM, or b) increased item
precision; their mechanisms may differ. IMPACT: How cognition should be engaged in educating children
and addressing learning disorders depends on basic mechanisms of WM development, which we must uncover.

Public health relevance
PROJECT NARRATIVE Working memory, the limited information held temporarily in mind, is needed for language and problem- solving capabilities throughout childhood development, and understanding and maximizing these capabilities requires a better understanding of the typical development of working memory. In R01 HD021338 we have found that several popular accounts of what improves with development are insufficient, and have developed techniques to examine new hypotheses with various confounding factors controlled. In this renewal grant we examine working memory between 6 years and adulthood with new control methods, such as analyzing memory for two kinds of information at once; our initial results suggest a surprising developmental hypothesis in which children improve in the ability to use less attention by encoding more features and patterns into memory.